Improving monthly drills and instruction in East Coast Fisheries by developing relevant training aids.

RFA-OH-20-003: Commercial Fishing Occupational Safety Training Project Grants (T03) Project Summary/Abstract The proposed project will improve the quality and availability of safety training by developing videos as training aids that specifically address the high risks in the East Coast fisheries. Many fishermen on the East Coast have received no safety training or less training than required by federal law. In addition, the stigma associated with behavioral health issues like substance use disorder and coping with trauma, makes it difficult for fishermen to address health issues that make unsafe work environments. The combination of a dangerous profession, an untrained workforce, and a reluctance to engage on addiction and behavioral health issues, has resulted in catastrophic occupational health outcomes for fishing communities. The holistic approach used by Fishing Partnership Support Services (FPSS) and its partners builds a culture of safety through hands-on training in fishing communities, apprentice programs, and mental health intervention. This project will augment that effort by creating the training aids that graduates of these courses can use to conduct monthly instruction and drills on their vessels. Regular training through drills and instruction through videos and other resources is essential to building a culture of safety, improving response actions to emergencies, and coping with the effects of injury and loss. FPSS, a non-profit, will lead the project to create videos on abandoning ship, immersion suits, Coast Guard dewatering pumps, flooding, man overboard prevention and recovery, opioid substance use disorder, and coping with trauma. These videos will feature leaders in East Coast fishing communities, a key component to inspiring other fishermen to make safety and occupational health a priority.

Public health relevance
RFA-OH-20-003: Commercial Fishing Occupational Safety Training Project Grants (T03) Project Narrative The proposed project will improve the quality and availability of safety training by developing videos as training aids that specifically address the high risks in the East Coast fisheries. Many fishermen on the East Coast have received no safety training or less training than required by federal law. In addition, the stigma associated with behavioral health issues like substance use disorder and coping with trauma, makes it difficult for fishermen to address health issues that make unsafe work environments. The combination of a dangerous profession, an untrained workforce, and a reluctance to engage on addiction and behavioral health issues, has resulted in catastrophic occupational health outcomes for fishing communities. The holistic approach used by FPSS and its partners builds a culture of safety through hands-on training in fishing communities, apprentice programs, and mental health intervention. This project will augment that effort by creating the training aids that graduates of these courses can use to conduct monthly instruction and drills on their vessels. Regular training through drills and instruction through videos and other resources is essential to building a culture of safety, improving response actions to emergencies, and coping with the effects of injury and loss.